Wound Healing Preparations Incorporating Nitric Oxide- Releasing Materials

Develop and test a series of nitrac oxide releasing ploy(acrylonitrile) (PAN.NO) compositions for efficacy in woulnd healing applications.